Core A: Administrative Core

PROJECT SUMMARY (CORE A)
The overall goals of the Administrative Core (Core A) are to provide scientific, programmatic and fiscal leader-
ship, facilitate lines of communication between the different researchers involved in the PPG, maintain cohe-
rence in the PPG’s overall and long-range goals, and ensure that resources resulting from the PPG will benefit
the scientific community. Core A will thus provide the mechanisms to manage, evaluate, and evolve the four
Research Projects and two Research Cores in the program. In the context of the above, the task of Core A will
be the effective coordination of the activities of all the components, such as the selection and design of jointly
used models and resources (cell lines, mouse models, transposon reporters, protocols, etc.), the development
of new technologies and tools to more effectively promote the research goals, and enabling the scientific
community access to the PPG’s resources, technologies, and databases. The following activities will also
contribute to achieving these overall goals: 1) Core A will ensure that the administrative and financial
requirements of the NIH and the participating institutions are met; 2) Core A will organize monthly
videoconferences and annual face-to-face retreats; 3) Core A will be responsible for communications between
the PPG and the NIH; 4) Core A will facilitate the submission of joint publications and, in collaboration with Core
B, the deposition of high-throughput datasets into public databases; 5) Core A will establish the External Advisory
Board (EAB) and organize the annual reviews of the PPG.